"Understanding the role of arginine metabolism in antibiotic treatment failure during Staphylococcus aureus infections."

PROJECT SUMMARY
Staphylococcus aureus is a leading cause of a wide range of bacterial infections globally and the most
common bacterial cause of mortality in the United States. This is also true among Veterans, where S. aureus is
a leading cause of many common infections and is associated with roughly one out of every 50 admissions to a
VA hospital. Veterans are at increased risk of S. aureus infections due to the increased incidence of co-
morbidities such as diabetes and renal failure, both of which have been shown to increase the risk and severity
of S. aureus infections. In addition, diabetes and renal disease have been shown to increase the rates of
recurrent S. aureus bacteremia specifically among Veterans. These poor outcomes are driven by the high rates
of antibiotic treatment failure (15-40%) seen with many types of S. aureus infections including osteomyelitis,
prosthetic joint infections, and endocarditis. Antibiotic tolerance, which is defined as the ability of bacteria to
survive in the face of antibiotics through phenotypic changes without the acquisition of antibiotic resistance, is
the major driver of antibiotic treatment failure in S. aureus infections. Even with appropriate antibiotic therapy,
mortality rates can exceed 20% for some of these infections. Given the high incidence of S. aureus infections,
the frequent treatment failure, and the elevated risk for more severe outcomes among Veterans, new and
improved treatment options are needed to combat S. aureus infections.
Despite the clinical significance of antibiotic tolerance, the mechanisms by which it occurs are poorly
understood. To understand the mechanisms leading to treatment failure in S. aureus infections, my fellowship
research focused on understanding antibiotic tolerance by conducting comprehensive, unbiased genetic and
proteomic screens of S. aureus during antibiotic exposure. With this approach, I identified a previously unknown
relationship between antibiotic tolerance and arginine metabolism. My preliminary experiments identified an
increase in antibiotic tolerance in mature S. aureus communities when arginine is depleted. In addition to being
an essential amino acid for S. aureus growth, arginine is also required for the production of nitric oxide by host
immune cells such as neutrophils and macrophages. The importance of nitric oxide production to the host
response to S. aureus infections, establishes arginine as an important contributor to the ability of the immune
system to combat S. aureus. Collectively, these results support the hypothesis that S. aureus influences arginine
levels during infection by carefully regulating arginine metabolism as a means to survive both in the face of
antibiotics and the innate immune response. Through this proposal, I plan to test this hypothesis by (1)
elucidating the mechanism(s) by which arginine metabolism influences antibiotic tolerance in S. aureus, (2)
determining the role of S. aureus arginine metabolism in persistence in the presence of innate immune effector
cells, and (3) identifying the contribution of S. aureus arginine metabolism to persistence and antibiotic treatment
failure during infection. Together, these experiments will better define the role of an essential amino acid at the
host-pathogen interface. The work in this proposal has the potential to uncover new targets for therapeutics to
address the issue of treating recalcitrant infections that fail conventional therapies. In addition, through this
Career Development Award, I will receive important mentorship while gaining specific research skills in animal
models, eukaryotic cell culture, and imaging mass spectrometry. This VA CDA-2 will help me establish my own
independent research program as part of my long-term goal of becoming a VA physician-scientist leader in the
field of infectious diseases with an expertise in bacterial pathogenesis and antibiotic treatment failure.

Public health relevance
PROJECT NARRATIVE Staphylococcus aureus is a leading cause of many common infections among Veterans and is associated with roughly one out of every 50 admissions to a VA hospital. Furthermore, S. aureus is the most common bacterial cause of mortality in the United States. These high rates of mortality are driven by elevated rates of antibiotic treatment failure, which exceeds 15% for some S. aureus infections. Despite the clinical significance of antibiotic tolerance, the mechanisms by which it occurs are poorly understood. Depletion of arginine leads to an increase in antibiotic tolerance in mature S. aureus communities. Using a combination of in vitro experiments, tissue culture, in vivo mouse infection models, and advanced imaging mass spectroscopy, I will test the hypothesis that S. aureus is able to regulate the level of arginine to promote its own survival and persistence in the presence of antibiotics and the innate immune system.